Bladder Dysfunction and Dysregulation of Neurotransmission

Bladder dysfunction is a common, distressing finding in patients afflicted with two
disorders that are increasingly prevalent in the general population but significantly over-
represented in the veteran population—type 2 diabetes (T2DM) and Parkinson’s disease (PD).
Currently, treatments for bladder dysfunction address the symptoms, not the cause, which
remains largely unknown. Though bladder dysfunction manifests early in the course of each
disease, it frequently remains unrecognized and worsens with disease progression. T2DM and
PD can occur independently, however these disorders are related and sometimes coincident. It
has been shown that T2DM increases the risk of PD, and PD patients with T2DM develop more
aggressive motor and cognitive impairment. Such reciprocity is likely to spring from a common
biochemical mechanism underlying the pathogenesis of both chronic diseases, with adverse
consequences for bladder function. The pathology of PD is associated with aggregation of alpha
synuclein (αSyn), a protein abundant in presynaptic nerve varicosities whose biological function,
though incompletely understood, encompasses a role in facilitation of neurotransmission. In this
proposal, we present and rigorously test our proposed mechanism of αSyn interaction with the
unconventional motor protein, myosin 5a (Myo5a), as well as with cytoskeletal actin, in functional
processes involving neurotransmission and glucose regulation in the bladder. We will examine
perturbation of this mechanism in both T2DM and PD animal models and under in vitro
hyperglycemic conditions. We also propose to investigate the influence of glucagon-like peptide
agonists, agents used in T2DM treatment, on restoring the αSyn-Myo5a-actin axis. The
multidisciplinary studies proposed herein will integrate biochemical, molecular, cellular and
physiological approaches that exploit state of the art methods combined with proven conventional
techniques. The information gained will provide a foundation for more effective interventions
addressing the foundational causes of bladder dysfunction and deficits in bladder
neurotransmission in patients with T2DM and PD.

Public health relevance
Bladder dysfunction is highly prevalent in the aging veteran population and is the most common complication of diabetes and Parkinson’s disease. Disorders of the bladder are often ignored or overlooked in those with comorbidity, which can lead to a devastating series of pathological events. The negative impact of bladder dysfunction on the physical, mental, emotional and social health of the veteran population, as well as on the financial and healthcare delivery responsibilities of the VHA, underlie the critical need to better understand and manage problems related to the bladder. This proposal will investigate a novel signaling complex underlying bladder neurotransmission that is disrupted by diabetes and Parkinson’s disease. New insights regarding this shared bladder neuropathology will establish a foundation for design of better targeted pharmacotherapy and provide opportunities for early intervention of progressive neurogenic bladder dysfunction.